SAFETY OF LAMOTRIGINE AS ADD-ON THERAPY IN OUTPATIENTS WITH PARTIAL SEIZURES

Evaluate the long-term safety of doses of lamotrigine up to 500mg/day relative to placebo as add-on therapy in epileptic outpatients with refractory partial seizures.